Enhancing durability of V3 glycan vaccine responses in rhesus macaques

ABSTRACT
Developing an HIV vaccine capable of eliciting a durable broadly neutralizing antibody (bnAb) response is
needed for ending the HIV/AIDS epidemic. Inducing bnAbs will likely require a sequential vaccination approach
with perhaps 5 to 6 immunizations. High and sustained bnAb titers should be elicited only after preceding
immunizations drive affinity maturation of bnAb lineages. Inducing high antibody titers at earlier stages of the
vaccine regimen could interfere with the subsequent steps of bnAb affinity maturation. Thus, learning how to
induce a durable bnAb response would best be accomplished in the context of a vaccine regimen that is capable
of inducing affinity matured bnAb lineages. This proposal leverages a novel 6-shot germline-targeting HIV
vaccine regimen that has been validated to elicit a specific genetic-class (BG18) of cross-clade neutralizing
antibody in non-human primates. Investigating the last step of the sequential regimen will allow us to probe the
durability of the BG18-class long-lived plasma cells that have undergone the necessary affinity maturation. We
will systematically investigate four key concepts: (1) assessing the inherent durability of a 6-shot sequential
vaccine regimen that induces BG18-class cross-neutralizing antibodies in non-human primates; (2) evaluating
the impact of a yearly maintenance shot on durability and whether deflecting competitor antibody responses
during these boosts is necessary; (3) evaluating nanoparticle or fractionated escalating dose trimer delivery for
the last immunization to improve durability; (4) investigating whether an mRNA sequential regimen with a last
boost of adjuvanted protein, generates a durable bnAb response. To address these concepts, we will probe key
immunological outputs such as quantification of B cell populations, including memory B cells in PBMCs, germinal
center B cells in lymph nodes and long-lived plasma cells (LLPCs) in bone marrow. Additionally, monoclonal
antibody and serum responses will be characterized for immunodominance, binding and neutralization capacity.
By focusing on the final stage of a multi-step HIV vaccine regimen, that induces cross-neutralizing BG18-class
responses, this project will explore durability in the phase of HIV vaccine development that was previously
inaccessible to detailed investigation; post-elicitation of matured bnAb lineages. Identifying the immune outputs
that most closely correlate with bnAb durability will be a central goal, providing invaluable insights for optimizing
the design of an effective HIV vaccine.

Public health relevance
An HIV vaccine will need to elicit protective antibodies with exceptional durability to be effective. There are several questions about how to improve the durability of an HIV vaccine. We will evaluate and optimize various approaches to enhance durability of a promising HIV vaccine regimen that has been developed in non-human primates.